Career Development of Environmental Health Investigators

CAREER DEVELOPMENT Specific Aims The Center's Career Development Program will provide training and mentoring for junior basic and clinical scientists with interests in environmental health sciences with the aim of assisting them in the development of productive independent research careers with an emphasis in the environmental health sciences and bringing them to full Center membership.